Bruker Single Cell Proteomics Mass Spectrometer System

PROJECT SUMMARY
The long-term goal of this proposal is to advance the research of investigators at The Jackson Laboratory
(JAX) and in the Maine research community by bringing a new Bruker timsTOF SCP mass spectrometer
package for high-resolution, single-cell proteomic analysis to JAX’s Mass Spectrometry and Protein Chemistry
Service (MSPC). JAX’s research mission focuses on discovering precise genomic solutions for disease to
improve human health in the global community. As part of this mission, there has been an increasing emphasis
on the analysis of single cells, as biomedical research has demonstrated that examination of biology at this
level is essential for understanding the biological processes underlying development and disease. Accordingly,
JAX has technologies for characterization and quantification of gene expression, chromatin accessibility, and
individual cell-surface protein molecules present, all at the single-cell level. In addition, recently JAX
investigators have had access to increasingly advanced capabilities in the MSPC in mass spectrometry-based
proteomics and metabolomics for biological discoveries linking genomics with phenotype. However, despite
our numerous mass spectrometry capabilities, there is currently no instrumentation here with the capability to
perform unbiased, high-throughput label-free single-cell proteomics analysis. This gap limits our investigators’
ability to understand biology at the single-cell level, including new insights that would be gained by integrating
single-cell proteome data with the array of other single-cell data generated here, and by addressing the issue
of a generally weak transcriptome-proteome correlation in organisms. The Bruker timsTOF SCP mass
spectrometer is the ideal system to address this gap. This instrument offers innovative technologies, including
a dramatically improved ion-source concept, an enhanced trapped ion mobility, and mass analyzer that provide
ultra-high sensitivity, enabling unbiased single-cell proteomics with high reproducibility. The timsTOF SCP can
achieve coverage of about 1,500 proteins per cell, sufficiently identify post-translational modifications in a very
small number of morphologically or functionally similar cells, and efficiently analyze low-abundant samples,
such as the rare cell populations that many of our investigators study. The timsTOF SCP and its accessories,
including the cellenONE for single-cell sorting and proteomic sample processing, will be transformative for
research at JAX and other Maine research institutions. Various studies at JAX focused on rare immune-cell
populations, stem-cell differentiation, sub-populations of cancer cells, the identification of new therapeutic
targets for cancer, and characterizing mechanisms underlying cognitive aging will all benefit from this
instrumentation. Progress in these research areas are particularly important given JAX’s broadening emphasis
on translating our basic research discoveries into clinical advances that will directly benefit human health. In
sum, the Bruker timsTOF SCP platform will substantially enhance JAX’s ability to fulfill its research mission and
will also bring this potential to the greater Maine community.

Public health relevance
PROJECT NARRATIVE Recent advances in biomedical research have demonstrated that analysis of single cells is essential for understanding the biological processes underlying development and disease. At The Jackson Laboratory (JAX), we have the capability to analyze diverse components in the pathways involved in protein production, including RNA and DNA molecules, and other molecules that modify levels of proteins generated from RNA or DNA, but currently we have no options for high-throughput identification of the “proteome,” i.e., the complete set of proteins, in a single cell. Access to the Bruker timsTOF SCP mass spectrometer and the accompanying cellenONE for sample processing requested in this application will provide investigators at both JAX and other Maine research institutions with access to a state-of-the-art single-cell proteomics system that will significantly advance research on a broad range of diseases.